EFFECTS OF GLUCOCORTICOIDS AND IGF 1 ON BONE FORMATION

Osteoporosis is often a consequence of glucocorticoid therapy and pathological conditions in which endogenous glucocorticoid level are elevated. Glucocorticoid induced osteoporosis is due to an increase of bone resorption and a decrease in bone formation. Glucocorticoids are important regulators of bone formation, although, their effects are often paradoxical. While physiologic concentrations of glucocorticoids promote osteoblast differentiation in primary cultures of calvarial and bone marrow stromal cells, pharmacological concentrations inhibit bone formation by decreasing osteoblast renewal and function. Insulin-like growth factor I (IGF-I), however, is anabolic for bone formation. It been have previously shown that IGF-I can prevent the inhibitory effects of glucocorticoids in organ cultures of fetal rat calvaria. In this proposal, we will take advantage of transgenic approaches to design new and more definitive strategies for assessing the effects and interactions of Gcs and IGF-I on bone formation. First, it is hypothesize that overexpression of IGF-I in bone will increase bone formation and prevent the inhibitory effects of glucocorticoids in vivo. Second, it is suggested that IGF-I null mice will have defects in bone formation and will be susceptible to the inhibitory effects glucocorticoids on bone formation. Third, it is hypothesized that in vivo glucocorticoids willlimit the osteogenic differentiation of ex vivo bone marrow stromal cell cultures by depleting the marrow of progenitors. These hypotheses will be addressed will be addressed with the following models: A unique trans-genic mouse will be developed in which IGF-I expression is specifically targeted to bone by a COL1A1 promoter fragment that is highly expressed in bone but not most other tissues. Organ cultures of calvaria from fetal IGF-I null mice will be studied. Finally, mice with be treated with glucocorticoids in vivo and the differentiation of ex vivo bone marrow stromal cell cultures examined in vitro. These studies will provide insights in to the interactions of glucocorticoids and IGF-I on bone and show whether or not targeted growth factor expression in mice will prevent the inhibitory effects of glucocorticoids on bone formation.